Community Engagement and Training Core

MISSISSIPPI INBRE
COMMUNITY ENGAGEMENT AND TRAINING CORE
Project Summary/Abstract
The state of Mississippi continuous to be infamous for poor health outcomes in general and particularly among
African Americans, a predominant minority and underserved population in the state. In order to address these
issues, we propose to expand the mission of the Community Engagement and Training Core (CETC) to
improve research capacity and provide outreach opportunities for student, faculty and community members in
the state. This core will provide the infrastructure for faculty and students at undergraduate institutions to
conduct community-based participatory research in Mississippi. Additionally, the core will focus on obesity and
HIV as two preventable conditions that disparately impact minority populations. The CETC will address the
following aims: 1) Provide training and mentorship opportunities for students that emphasize an
interdisciplinary approach to solving public health issues; and 2) Provide research opportunities for faculty and
students to engage in telehealth, community-based participatory and/or translational research. At the
completion of this project, we expect an increase in community-based research capacity in Mississippi
particularly at undergraduate institutions and an increase in the number of students educated and trained in
public health and health disparities.